Construction of cell specific gene co-regulations signatures based on single cell transcriptomics analysis

Project Summary/Abstract Not Applicable

Public health relevance
Project Narrative Not Applicable